BLRD Research Career Scientist Award Application

Dr. Charles Jeffrey Smith’s current research activities and primary research goals focus on three distinct areas:
1. The Smith Laboratory research program at the Harry S. Truman Memorial Veterans’ Hospital (HSTVA) is
focused on the development of improved radiopharmaceuticals for early diagnosis and more effective
treatments for prostate and breast cancer patients.
• Since Dr. Smith’s independent funding portfolio began in 2004, his research efforts have been supported
primarily by VA and NIH funding mechanisms. His current Merit Review Award (BX000964) focuses on
utilizing phage display technology to identify novel cell-targeting probes for the design/delivery of
radiopharmaceuticals that target prostate and breast cancer.
• As a result of direct and collaborative research projects, Dr. Smith has authored or co-authored 70 peer-
reviewed publications, 4 review articles, 13 books/book chapters, and six (6) successful US Patent
applications. In addition, he has authored or co-authored 26 professional reports or peer-reviewed
proceedings from a research meeting.
• As part of his VA Research program, Dr. Smith has continued to serve as a mentor to post-doctoral fellows,
graduate students, and undergraduate students from the University of Missouri (MU) Departments of
Chemistry/Radiology and also to M4 medical students from the School of Medicine.
• As a Professor in the Department of Radiology at MU, Dr. Smith has been a facilitator of Patient Based
Learning (PBL) for medical students in Pathophysiology 4, Blocks 5 (Fall) and 8 (Winter) since 2006 and
2012 to the present.
• As faculty in the MU Department of Radiology, Dr. Smith has served as a research mentor to M4 medical
students who have worked in his laboratory to gain experience with radiopharmaceutical science research.
• An additional component of Dr. Smith’s research program has been in directing the Radiopharmacology
Core, which provides HSTVA and MU investigators with expertise for pre-clinical rodent studies in agent
administration, surgical services, biodistribution, therapeutic assessment, and small animal imaging
investigations.
2. The HSTVA Biomolecular Imaging Center (BIC) serves as a resource for HSTVA and MU to provide state-
of-the-art small animal molecular imaging instrumentation for research purposes. Dr. Smith became the
Director of the HSTVA BIC in August of 2023. The VA BIC equipment is operated on a fee-for-service model
by specially-trained individuals who work with the investigator in designing and executing varying small
animal research objectives.
3. The HSTVA Open Field Blast Center (OFBC) facility is a VA Office of Research & Development (ORD)
supported center which provides VA investigators with access to an open field blast mild traumatic brain
injury (mTBI) animal model. Dr. Smith became the Director of the VA OFBC in August of 2023. The OFBC
works with VA investigators across the country to provide a model of mTBI to them and also to offer
specialized services in the areas of neurobehavior assessment, neuroimaging, and/or ocular assessment
of these animals. In addition, the OFBC provides a mechanism for shipment of these animals back to the
VA investigator to address additional research questions related to the blast environment and mTBI.

Public health relevance
For nearly 20 years, Dr. Charles J. Smith’s (Jeff) research group has focused on improving the diagnostic and therapeutic efficacy of radiopharmaceuticals used in prostate and breast cancer patients. He is the Director of the Harry S. Truman Memorial Veterans’ Hospital (HSTVA) Biomolecular Imaging Center (BIC) and the VA Open Field Blast Center (OFBC). The VA BIC provides state-of-the-art molecular imaging expertise and services to HSTVA and non-VA investigators using small animal CT/MRI/SPECT/PET/optical instrumentation. The VA OFBC provides mild traumatic brain injury (mTBI) small animal models (using an open field blast method of injury) to VA researchers across the country. OFBC also offers neurobehavior, neuroimaging, and ocular assessment in these animal models. His team continues to work to improve cancer diagnosis/treatment strategies while the BIC and OFBC expands this scope further to work towards the VA mission to “improve Veterans’ health and well-being via basic, translational, clinical, health services, and rehabilative research”.